Preclinical validation of small molecule immunomodulators for the treatment of Crohn's disease

Project Summary
Crohn’s disease is a debilitating and chronic inflammatory disorder of the gastrointestinal tract characterized by
aberrant healing and intestinal stricturing. In the US, >500,000 patients suffer from Crohn’s disease and over
30,000 patients are newly diagnosed each year. No curative treatments exist. Instead, current treatments focus
on managing symptoms and reducing the occurrence of new episodes. New treatments are urgently needed.
We hypothesize that targeted modulation of the intestinal mucosal barrier and local immune signaling in
the bowel can reverse disease progression. A promising way to modulate immunity and mucosal healing is
utilizing molecules that are released by commensal bacteria in the gastrointestinal tract as the immune system
has evolved specific ways to interact with these molecules. However, besides some preliminary data showing
that such molecules protect against acute bowel inflammation in mice, the utility of these immunomodulatory
molecules for treating bowel inflammation remains unclear. We have developed a new molecule inspired by
these bacterial molecules that shows improved protection against bowel inflammation upon intraperitoneal
injection in an acute mouse model of bowel inflammation. However, it is unclear whether our molecule can be
administered orally instead of by injection. Thus, in the first part of this project, we will evaluate the therapeutic
effect of our molecule upon oral administration in mice experiencing acute bowel inflammation.
Next, as acute models of bowel inflammation only mimic certain aspects of disease and fail to capture
the multi-faceted, chronic, progressive inflammation observed in Crohn’s disease, we will further validate
whether our molecule provides a promising therapeutic strategy for Crohn’s disease by examining our
molecule for its therapeutic effect in a genetic mouse model of spontaneously developing, chronic bowel
inflammation. This mouse model relies on an engineered genetic defect in the Mdr1a gene. MDR1A plays a
role in the regulation of innate and adaptive immunity in the intestinal mucosa. Upon genetic inactivation of
Mdr1a, mice develop chronic bowel inflammation at 8-14 weeks of age that more closely resembles what
occurs in Crohn’s disease patients than chemically induced acute models. Thus, positive results in this Mdr1a-/-
mouse model will provide further validation for the utility of our class of molecules for treating Crohn’s disease.
At the completion of these studies, we expect to have determined whether our molecule can be used
orally and whether it can protect mice from chronic bowel inflammation that more closely resembles Crohn’s
disease. The results from these studies are critical to define the next steps in the drug development process of
our molecule, which is aimed at developing an easy-to-use, gut directed therapeutic for Crohn’s disease. This
is important because current treatment options for Crohn’s disease show limited efficacy and often require
(self)-injection. Crohn’s patients look forward to new and practical, non-immunosuppressive drugs.

Public health relevance
Project Narrative Crohn’s disease is a debilitating and chronic inflammatory disorder of the gastrointestinal tract that affects over 500,000 patients in the US. There is no cure for Crohn’s disease and current therapies fail to address the cause of the disease. Our proposed studies are aimed at validating a new treatment strategy for Crohn’s disease inspired by naturally occurring bacterial molecules that regulate the immune system in the intestines to support wound healing and immunotolerance. If successful, our research is expected to initiate the development of new drugs that follow a different therapeutic paradigm than the current drugs and that might be used by patients in the clinic within 4-6 years.